Characterizing and Mitigating the Role of Oxidative Damage in Microelectrode Failure

The Capadona group has identified the role of inflammation-mediated oxidative stress products in
microelectrode-initiated neuroinflammation to be the most comprehensive source contributing to poor
electrode reliability. In order to realize the potential of any application using intracortical microelectrodes,
we must minimize the degradative side effects caused by oxidative stress products, without inhibiting the
beneficial wound healing aspects of inflammation.
We have used a variety of antioxidant treatments to demonstrate a reduction in intracortical
microelectrode-mediated oxidative stress and preserve neuron viability. Our most promising strategy to
date for improving intracortical recording reliability is our biomimetic antioxidative coating. Our initial
efforts focused on planar silicon substrates for ease of characterization, cost, and their recent popularity
in the literature. Our preliminary data suggest that our novel antioxidative-coated microelectrodes reduce
the initial inflammatory response, preserve neuron populations, and improve initial recording quality.
The initial mimetic coating is not a comprehensive antioxidative strategy. Oxidative stress can be
initiated by either a damage-associated molecular patterns (DAMPs) or pathogen-associated molecular
patterns (PAMPs) pathway. In the proposed study, we will specifically investigate the effect that
antioxidant-coated microelectrodes have on the stability of stimulation and neural recordings. Our
electrodes will be coated with antioxidants that target either PAMP, DAMP, or both PAMP and DAMP
pathways, in order to develop a comprehensive, but not overly suppressive approach.
In order to be applicable to on-going clinical trials, our coating must also be translatable to the only
penetrating recording microelectrode approved by the US FDA. Therefore, we have shown that these
antioxidants can be attached to Parylene C. The innovation of this proposal is in the application of a
platform approach to surface modify Parylene C coated Blackrock Arrays, to effectively minimize two of
the leading causes of intracortical microelectrode failure: materials damage and biological damage.
On a more fundamental level, this work will also examine how varying the dimensions of intracortical
microelectrodes impacts both ROS and the tissue response. Extremely thin devices, regardless of
inherent Young's modulus of the constituent material, become very flexible. Due to its high fracture
resistance, we will leverage amorphous silicon carbide to create microelectrode probes with small
thicknesses. Such probes will enable us to test the hypothesis that oxidative stress and
neuroinflammation are proportional to the device dimension and resulting rigidity. We will further
demonstrate that the associated oxidative stress and neuroinflammation generated from larger more rigid
devices can be subdued by coating the implant with antioxidants.

Public health relevance
Intracortical microelectrodes have been hindered by the inflammatory reponse and materials failure, which yields the electrodes incapable of consistent stable interactions with viable neurons. Oxidative damage has been proposed as a dominant mechanism that mediates the inflammatory response and degration of electrode components. In this study, we investigate the ability of antioxidative coatings to improve the stability of chronic microelectrode stimulation and recordings to ultimately impact clinical use.